Training Program in Investigative Gastroenterology and Hepatology

The burden of digestive diseases in the United States is staggering, with annual costs exceeding $140 billion,
based on National Institutes of Health (NIH) estimates. To meet this challenge, a key mission of the National
Institutes of Diabetes and Digestive and Kidney Diseases (NIDDK) is to support the training of a talented, diverse
pool of young investigators who will attack scientific unmet needs to improve the lives of patients with
gastrointestinal and liver diseases.
The Icahn School of Medicine at Mount Sinai (ISMMS) has been a center of excellence for care in gastrointestinal
and liver diseases for decades, with clinical fellowship programs in these disciplines consistently ranked among
the best in the country. Moreover, ISMMS offers a fertile environment from which a cadre of outstanding
candidates have launched successful careers in academic gastroenterology and hepatology. The overarching
goal of this Training Program proposal is to leverage this outstanding environment to support the training of
M.D., M.D./Ph.D or Ph.D. postdoctoral fellows by providing exceptional research opportunities and mentorship
in three broad areas: A) Gastrointestinal inflammation and the microbiome; B) Non-alcoholic steatohepatitis
(NASH), hepatic inflammation and fibrosis; and C) Genetics of gastrointestinal and liver diseases. The highly
structured training program provides a tailored curriculum that integrates clinico-epidemiologic-, genetic-,
environmental- and cellular/molecular research excellence. The program is built upon a foundation of world class
research faculty who have outstanding track records of academic achievement and successful mentorship. The
curriculum focuses on cross-disciplinary training in order to prepare trainees for the current and future challenges
of gastrointestinal and liver disease research, which now requires integration of complementary research skill
sets. To address this need, a highly selected pool of mentors has been chosen not only from within the Divisions
of GI and Liver Diseases and other clinical disciplines, but who also represent outstanding multi-disciplinary
institutes at the ISMMS.
Each year this program will support 3 trainees (PGY 4 - PGY 6), with 15 candidates entering the program over
5 years. Each trainee will pursue an individualized research project and tailored curriculum formulated together
with their primary and secondary mentors, curriculum committee and the Program Directors. Trainees will
dedicate at least 90% effort in either the laboratory or clinical setting, and their progress will be monitored through
quarterly meetings with their advisory committee and program directors. Overall quality and adaptability of the
program will be ensured through oversight by internal and external advisory boards, based on compliance with
defined metrics of success for both individual trainees and the overall program. This rigorously structured and
closely monitored program, committed to excellence and built upon a rich scientific environment and outstanding
faculty, will yield superbly trained future leaders in investigative gastroenterology and hepatology.

Public health relevance
Advancing our understanding of gastrointestinal and liver diseases, a major public health problem in the United States, requires outstanding, cross-disciplinary training to promote paradigm-shifting advances that improve patient care. We propose to establish a multidisciplinary postdoctoral research training program in investigative Gastroenterology and Hepatology to foster the next generation of independent investigators through customized educational and research programs that empower trainees to attack unmet needs in gastrointestinal and liver diseases.